A Novel Instrument to Address Freezing of Gait in Parkinson's Patients

Project Summary/Abstract
Introduction. Parkinson’s Disease (PD) is a common neurodegenerative disorder that affects 1 million Americans
and 10 million individuals worldwide. One of the most debilitating and impactful symptoms of PD is Freezing
of Gait (FOG). FOG, defined as an episodic absence or marked reduction of forward progression of the feet
despite the intention to walk, is a common motor symptom of PD. FOG is a “mysterious phenomenon” with
a pathophysiology that is not fully understood. FOG decreases quality of life and activity level, and leads
to loss of independence and injurious falls. Surgical and pharmacological treatments are often ineffective in
reducing FOG; however, alternate interventions can be more efficacious. External prompts, such as auditory,
visual, or tactile cues, have been shown to help, but outcomes are mixed due to the individualized nature of
FOG—different cues are more or less effective depending on the individual and their present circumstances.
The ParkinSense System. The body-worn ParkinSense system will help PD patients prevent FOG and resume
ambulation when FOG occurs. The miniature, wireless ParkinSense instrument will be easily attachable to
existing prescription or nonprescription eyeglasses, or can be worn as a low-profile band under a cap or hat. Using
sophisticated on-board six degrees-of-freedom inertial sensing and online processing algorithms, the ParkinSense
system will automatically detect FOG and provide an individually calibrated and optimized combination of cues,
including: auditory (speech, music, or rhythmic beats), visual (transverse lines or a grid in the visual field),
and/or vibrotactile cues. The ParkinSense system also includes a limb-worn unit to perform supplemental
sensing and cueing directly to a leg. The ParkinSense system will enable delivery of multiple types of cues
alone or in any combination. Cueing can be provided automatically in response to a FOG event, manually
(controlled by the wearer), or continuously. Cue delivery (for example, the amplitude and frequency of the
tactile cues) can be optimized to provide maximum efficacy, unobtrusiveness, and comfort for individual users.
Further, the ParkinSense system will have the capability to adapt its cues; for instance, the cue rhythm can
match the functional step cadence of the wearer in order to maximize response. The ParkinSense system will
track FOG occurrence over time and the efficacy of each provided cue. These data will be used to further and
continuously personalize the system for each user; ParkinSense will become more effective for an individual as
it is used. Finally, ParkinSense will have a remote reporting capability that will allow clinicians to monitor their
patients health status over time (e.g., activity level, FOG occurrence, and adherence to device use).
Phase I Results. A ParkinSense prototype was designed, built, and evaluated by collecting data on patients
with PD using a FOG-inducing protocol. The ParkinSense system algorithms were shown to detect FOG with
high accuracy. A mixed-methods formative user-acceptance study demonstrated high acceptance, usability, and
enthusiasm for the ParkinSense system. All Phase I objectives were achieved.

Public health relevance
Project Narrative The objective of the proposed work is to develop the intelligent, easy-to-use, unobtrusive ParkinSense system to assist PD patients with freezing of gait symptoms by providing an optimal, personalized cueing strategy. The proposed system will improve quality of life for patients that suffer from FOG by reducing both the incidence of FOG and the duration of FOG episodes through its multimodal, individualized, and adaptive smart cueing capability. The unobtrusiveness of the ParkinSense system, its wide range of cue varieties, and its ability to automatically detect FOG and provide the exact type of cues that are most effective, will be appealing, practical, and efficacious compared to existing systems.